GFR MEASUREMENT IN TYPE II DIABETICS WITH MILD RENAL IMPAIRMENT

To investigate the glomerular infiltration rate in type II diabetics using iothalamate clearance determinations as compared to simultaneously collected creatinine clearances.